Imaging and Radiation Sciences

UWCCC Imaging and Radiation Sciences Program Summary
Co-Leaders: Robert Jeraj and Randy Kimple
PROJECT SUMMARY/ABSTRACT
The Imaging and Radiation Sciences (IR) Program’s mission is to integrate physical and biological sciences with
clinical research and clinical practice to improve cancer diagnosis, therapy, and the lives of patients with cancer.
The exceptional environment within the UWCCC and the IR program provides an opportunity to advance
imaging, radiopharmaceutical, molecularly-targeted radiobiology, and radiation therapy across the translational
science spectrum from basic mechanisms through clinical trials. These goals are achieved through three
connected aims. Aim 1: To develop and translate innovative imaging agents and technologies to improve
cancer detection and treatment response assessments. IR program members focus on development and
translation of novel molecular imaging agents, such as radiolabeled nanomaterials, refinement of quantitative
imaging methods, and development of innovative image-analysis techniques, including advanced artificial
intelligence methods. Aim 2: To develop and translate radiopharmaceuticals for more effective
personalization of systemic radiation therapies. IR program members focus on development of novel
positron and low energy electron-emitting radionuclides and radiopharmaceutical delivery vehicles, combinations
of radiopharmaceuticals with immunotherapy, and the development and clinical translation of theranostic agents.
Aim 3: To develop and translate advances in the management of localized radiation therapies to improve
therapeutic response and minimize side effects. IR program members focus on localized tumor ablation,
combining localized therapies with systemic therapies to target oligo-resistance, understanding molecular
mechanisms underlying therapeutic resistance, and reducing treatment toxicities through novel cellular therapies
and by employing unique combinations of imaging and treatment planning to improve the quality of therapeutic
interventions. Notable achievements since the last CCSG renewal include doubling clinical trial accrual
compared to the time of the last CCSG renewal, with many of trials being translated nationwide reflected by
almost 40% of IR members holding leadership roles in cooperative groups. IR members have received multiple
large multi-investigator studies including an Immuno/Radiopharmaceutical P01, a UG3/UH3 supporting a first-
in-human study of cell therapy for treatment of radiation-induced xerostomia and have been in key leadership
roles in the Head and Neck cancer SPORE renewal (favorably reviewed) and breast and prostate cancer SPORE
grant submissions. These productive efforts are well supported: 41 members from 6 departments have a total of
$9.8M in annual direct costs ($3.4M from NCI, double compared to the prior cycle). These research efforts have
led to 897 peer-reviewed publications in the last five-year funding period, including an exceptional 19% in journals
with impact factors >10, with intra-programmatic publications increasing from 14% in 2017 to 31% in 2022 and
inter-programmatic increasing from 12% to 18% over the same time.

Public health relevance
PROJECT NARRATIVE Per PAR-21-321 instructions, this component is not required.